Testing a Clinician and Patient Intervention to Promote smoking Cessation Among Pregnant Women

Perinatal smoking negatively affects the baby and mother as well as healthcare costs; yet, up to one third of
women who smoke continue to do so during pregnancy. We tested an SMS texting program and found we
could help 10% quit. This quit rate is promising given the light touch and far‐reach of a texting intervention.
We want to build on this work to help more pregnant women quit. We will pair the texting intervention with
another far‐reaching intervention, clinician counseling —an evidence‐based intervention that has been shown
to increase rates of smoking cessation. Despite national guidelines to implement the 5 Aʹs—Ask, Advise,
Assess, Assist and Arrange—most obstetric clinicians only Ask and Advise, the least effective of the five. By
improving OB clinicians' smoking cessation counseling skills, we can potentially double the effect of the SMS
texting program and twice as many women quit. We have already designed and piloted an interactive,
individually‐tailored, web‐based communication training program. The program uses clips from OB
clinicians' own audio‐recorded encounters, and provides constructive, individualized feedback and
suggestions for incorporating the 5 Aʹs. The program is modeled after our other communication training
programs that successfully improved pediatrician use of the 5 Aʹs and oncologist use of empathic
communication. We propose a randomized, controlled trial to assess whether use of the communication
program improves cessation rates among pregnant women who smoke and whether it improves OB clinician
smoking cessation counseling. First, we will recruit 50 clinicians and will audio record 4 encounters in the Pre‐
Intervention Phase that will be used to tailor the intervention and assess baseline communication skills. Then,
we will randomize half of the clinicians to receive a tailored, web‐based intervention that contains didactic
information interactive exercises, and audio clips from their Pre‐Intervention recordings to promote their use
of the 5 Aʹs. Clinicians in the control arm will receive the standard smoking cessation counseling web‐based
designed for obstetricians. We will recruit 550 patients (11 per clinician), all who will receive the texting
intervention, and will audio record their encounters. We will use an intent‐to‐treat analysis to compare our
primary outcome, biochemically‐validated cessation at the end of pregnancy, among patients of intervention
(n=275) and patients of control OB clinicians (n=275). Additionally, we will assess clinician use of the 5A's in
smoking cessation counseling, patient perceptions of communication as well as smoking postpartum. If
successful, this program would have an exponential impact on increasing smoking cessation and improving
pregnancy outcomes.

Public health relevance
Even though smoking in pregnancy harms the baby, pregnant women struggle to quit smoking. We are coupling a texting program that helps pregnant women quit with a program to teach obstetric clinicians how to counsel women to quit. We expect that women will be most likely to quit when they receive both the texting and are counseled by a clinician who has learned effective communication.